Use of Reproductive Health Care among Asian Immigrant Women

Project Summary/Abstract
There are over 20 million Asians in the US, 60% of whom are immigrants. By 2055, this demographic is
expected to surpass Hispanics to become the largest immigrant group in the country. This includes 1.5 million
undocumented Asians, who experience greater barriers to access than their documented peers. Despite these
trends, national health statistics often lump Asians into an “other” category or exclude them entirely. For Asian
immigrant women, who report greater odds of unintended pregnancies and are less likely to use sexual and
reproductive health (SRH) care compared to their US-born counterparts, detailed SRH data accounting for
their diversity of social, economic, and political experiences is critical to addressing SRH inequities in their
growing community. Moreover, past studies treat immigration status as a binary (documented/undocumented)
and static variable; however, there is increasing recognition that there is a hierarchy of statuses and that status
can change across the life of an immigrant. Building on the PI’s past work with Asian immigrants, the goal of
this study is to provide critical SRH data among the most diverse sample of Asian immigrant women to date.
We propose to establish the first multi-city, sequential mixed-methods study of the SRH of Asian women
across multiple ethnicities and immigration statuses, including naturalized citizens, lawful permanent residents,
temporary workers and students, DACA recipients, and undocumented immigrants. Guided by the social
ecological model and life course perspective, this study will assess multilevel factors that mediate and
moderate associations between immigration status and SRH care use. We first conduct 48 qualitative life
history interviews to examine how sociopolitical experiences of immigration statuses act as barriers to SRH
care use over time (Aim 1). Next, using a novel starfish sampling method used to recruit hidden populations,
we will recruit 2,000 Asian immigrant women aged 18-49 years, including an oversampling of the four largest
undocumented Asian ethnicities (Indian, Chinese, Filipinos, and Koreans) in cities with the highest numbers of
Asian immigrants (Los Angeles, New York City, Houston, and Atlanta). Using quantitative survey data, we will
1) examine how immigration status is associated with use of recent SRH services; 2) explore histories of
immigration statuses and assess cumulative risks on SRH care use during sensitive periods (e.g. childhood,
adolescence, adulthood) (Aim 2); 3) and examine mediators and moderators (Aim 3). In order to improve the
quality, relevance, and accessibility of our research, we will partner with the National Asian Pacific American
Women’s Forum (NAPAWF), the first national Asian reproductive justice organization, and its chapters located
in each of our cities of interest. In addition, we will closely engage the knowledge, expertise, and sensitivities of
local community-based organizations throughout California, New York, Texas, and Georgia. Our short-term
goal is to identify and inform multi-level SRH outreach and intervention efforts, which will help us achieve our
long-term goal to improve the SRH equity of immigrants, families, and communities.

Public health relevance
Project Narrative Asian immigrant women have a higher risk of an unintended birth compared to White women, and are less likely to report recent use of sexual and reproductive healthcare compared to US-born Asian women. Despite these trends, there is a lack of disaggregated data by ethnicities and immigration statuses, contributing to the invisibility of Asian women. This study will significantly contribute to our understanding of the mechanisms and protective factors that moderate immigration status and use of sexual and reproductive healthcare and to the identification of novel community, social, and policy-level interventions that can improve the sexual and reproductive health of Asian immigrant women.